Determining the molecular basis for extreme virus stability, a structure-guided approach

PROJECT SUMMARY
In the long-term we aim to understand the genetic, biochemical and structural basis for extreme virus function
and stability. Sulfolobus Spindle-shaped Virus 1 (SSV1) is astonishingly stable to both high temperatures
(>80°C) and low pH (3 and below). This stability is despite being composed of proteins and nucleic acids with
similar compositions to viruses and other macromolecular complexes found in less extreme conditions.
However, it is not clear how SSV1’s extreme capsid stability is determined. We have developed robust genetic
tools for SSV1 and standardized techniques for working with these extreme viruses, and demonstrated their
use in undergraduate research. Together, these tools and the recently-determined structure allow probing of
the determinants of stability as follows.
Determine the amino acids in the SSV1 major capsid protein VP1 that are important for thermal
stability using site directed mutagenesis (Aim 1). We have determined that the spindle-shaped SSV1 virion
is composed of seven intertwined helical strands of the major capsid protein, VP1. Using the predicted
structure of VP1 and the virion structure, we will make site-directed mutations in 3 sets of amino acid side
chains: those predicted to be in loops and glycosylated, those predicted to make interactions between strands
and those predicted to form intramolecular interactions in VP1. These mutant viruses will be screened for
activity at multiple temperatures.
Use in vitro evolution to select SSV1 VP1 and VP3 mutants for increased thermal stability (Aim 2). In
order to perform an unbiased screen of amino acid substitutions that could confer stability to SSV1 we will
make a library of mutants that contain random substitutions in the major and minor capsid proteins VP1 and
VP3. These mutants will be selected in vitro for their ability to maintain infectivity at 80°C and 90°C.
Comparison of mutant libraries before and after selection with high throughput sequencing will be used to
determine which substitutions are permitted and which, if any, stabilize the virus.
Impact: Characterizing SSV1 mutants in vitro (Aim 1) and in vivo (Aim 2) will provide insight into fundamental
aspects of protein and virus stability including glycosylation. The identification of amino acid substitutions that
stabilize or destabilize SSV will help refine the SSV1 structural model. The results obtained in this project could
facilitate the creation of highly stable SSV-based nanoparticles, methods to destabilize pathogenic viruses and
produce stabilized vaccines. Finally, this project will allow Portland State University (PSU) students to engage
in cutting edge biomedical research and strengthen the PSU research environment.

Public health relevance
Project Narrative: Sulfolobus Spindle-shaped Virus 1 is an astonishingly stable virus, but we do not know how it or many other viruses are made to be stable. This research will use mutagenesis and artificial evolution to determine how virus proteins fit together to make stable virus particles. These results should allow the creation of highly stable nanoparticles and stabilized vaccines and may provide insights into how to destabilize pathogenic viruses, while strengthening the Portland State University research environment.